HABS-HD - Core D - Omics Core

HABS-HD OMICS CORE (CORE D) - ABSTRACT
Biofluids, including blood and CSF, alone or in combination, may provide sensitive biomarkers for Alzheimer’s
disease (AD) diagnosis, prognosis, and theragnosis. To date, however, no large-scale systematic multi-level
“omics” study has been conducted in combination with AT(N) defined (amyloid [A], tau [T], neurodegeneration
[N]) biomarkers among African Americans, Mexican Americans, and non-Hispanic whites. Our data suggests
that (1) omics-based biomarkers vary across diverse populations, including plasma AT(N) biomarkers, (2)
omics-based biomarkers can be highly accurate in detecting clinically diagnosed mild cognitive impairment
(MCI) and dementia across populations, but (3) the profiles differ between racial/ethnic groups. More recently,
our data suggests that a proteomic profile is accurate in detecting neurodegeneration, but again the profiles
vary between racial/ethnic groups. Given the documented differences in AT(N) biomarkers by racial/ethnic
groups, it is likely that multi-level omics investigations will highlight novel population-specific pathways for
cognitive decline, MCI and AD. Additionally, with the recent FDA approval of a disease modifying amyloid drug,
the data from the Omics Core (Core D) is more important than ever and can rapidly inform novel, appropriately
tailored, clinical trials. Core D will oversee the collection, processing, assays, storage and distribution of
samples to provide critical data to all Projects (Core – Project Interactions), Cores (Core-Core interactions),
and to global investigators (Cross-Cohort Interactions). Aim 1: Generate high quality genomic data. Aim 2:
Generate high quality proteomic data. Aim 3: Generate high quality exosome data. Aim 4: Generate high
quality metabolomic data. Aim 5: Provide critical omics data for projects (Core-Core, Core-Project
Interactions). Aim 6: Provide data and expertise to external investigators.